Bacteriophage-based Control of American Foulbrood in Honeybees

NIH Project Summary: This Small Business Innovation Research Phase I project will demonstrate feasibility for development of a bacteriophage-based preventative and treatment for American Foulbrood in honey bees. Phase I will focus on development of a bacteriophage treatment for P. larvae as a therapy for American Fouldbrood. In addition, efforts will be made to minimize the impact of the bacteriophage treatment on the commensal bacteria in the gastrointestinal tract of the honey bees. Phase II in vivo studies will be conducted at the experimental apiaries at the University of Arkansas. BioDetection Instruments will also work closely with the appropriate agencies to make certain that all regulatory requirements are met before the final product(s) is marketed.

Public health relevance
NIH Project Narrative: American Foulbrood is one of the most serious of bee diseases and has been reported on every continent in the world; presence of the disease requires notification to regulatory agencies because American Fouldbrood is highly contagious and can spread from one apiary to another. Honey bees are the most economically important pollinators world-wide, and if this project is successful and an effective treatment for AFB is successfully developed, there will be a profoundly positive effect on both the honey-making industry and agriculture at large.